Preclinical development of novel site blocking ASOs for the treatment of Rett syndrome

SUMMARY
An emerging theme in neurodevelopmental research is that both loss of function and overexpression of
the same gene can result in autism-associated phenotypes. This reality is epitomized by the disorder Rett
syndrome (RTT), where loss of function mutations in the Methyl-CpG Binding Protein 2 (MeCP2) gene are
pathogenic, but even a 1-fold increase over neurotypical levels evokes adverse effects. From a therapeutic
standpoint, the problem created by these narrow dosage requirements is that not only does viral MeCP2 delivery
need to be efficient across the entire human brain, but each cell must receive roughly the same, relatively small
amount. To address this challenge, our lab has developed an antisense oligonucleotide approach (ASO) to fine-
tune MeCP2 expression by outcompeting repressive miRNA for binding to the MeCP2 3’untranslated region
(UTR). As the contribution of each miRNA to gene expression is modest by nature, the result is an incremental
increase in mutant MeCP2 protein that saturates at a ceiling level predicted to be subtoxic. In contrast to
antagomirs, our site-blocking ASOs (sbASOs) are specific to the MeCP2 locus, and allow the target miRNA to
maintain all other binding partners. The sbASO proof of concept studies were recently published in “RNA”, and
show that sbASOs designed to outcompete miR22, miR132, and miR483 increase MeCP2 protein to levels that
plateau at a 0.4 to 2-fold increase, depending on the miRNA site being blocked. sbASO efficacy was established
in SH-SY5Y cells, wild-type mice, five RTT patient fibroblast lines, and RTT neuronal stem cells, where a
downstream MeCP2-signaling was also restored. Although exciting, we encountered the unexpected problem
that sbASO efficacy and potency were compromised by several highly prevalent MeCP2 mutations, narrowing
the approach’s utility. We have now resolved this challenge by establishing that certain classes of miRNA are
subject to mutation-specific regulatory feedback loops with MeCP2, while other classes are not. By blocking the
binding of one MeCP2-insensitive miRNA, miR181 (sb181), we observed robust efficacy and consistent potency
across five common MeCP2 mutations, suggesting that the sbASO strategy can have a broad therapeutic utility.
Here we propose a two-phase development strategy of our lead sbASO: sb181. In the R61 phase, we will
establish sb181 efficacy in iPSC-derived neurons from common missense mutations at the level of MeCP2
expression, downstream signaling, and cellular physiology. We will then define key DMPK and safety parameters
in a Mecp2T158M/+ mouse model, which will correlate sb181 exposure with Mecp2 levels as a function of
distribution, time, and RTT-like phenotypes. In the R33 phase, we will define the patient subpopulations where
sb181 would be predicted to be effective using additional missense (Mecp2R306C/+) and truncating (Mecp2R255X/+)
models of RTT. Together the R61 and R33 phases will establish the cell types and MeCP2 mutations impacted
by sb181, while also defining the DMPK and safety profile of the potential therapeutic, thereby facilitating the
transition to clinical development both with industry partners and the Blueprint Neurotherapeutics Network.

Public health relevance
NARRATIVE Monogenic neurodevelopmental disorders like Rett syndrome appear to be ideal candidates for gene therapy; however, replacing the causative gene (methyl-CpG binding protein 2, MeCP2) with traditional viral delivery strategies is complicated by a stringent requirement for protein dosage, whereby even a 1-fold increase over neurotypical levels evokes adverse effects. To address this challenge, our lab developed a series of antisense oligonucleotides (ASOs) designed to outcompete endogenous repressive miRNA for binding to MeCP2 and increase expression from the endogenous locus via a mechanism that saturates within the narrow safety window of the protein. We propose the continued advancement of our lead ASO, sb181, by defining key DMPK and safety parameters (R61) and identifying the patient subpopulations to be targeted during clinical development (R33).